Hypothalamic Pathways of Age Related Homeostatic Dysregulation

PROJECT SUMMARY
This project is designed to determine the role of hypothalamic neurons in the progression of physiological decline
with age. During summer heat waves, older adults are extremely vulnerable to hyperthermia and dehydration
leading to higher risk of morbidity and mortality. Understanding the cellular mechanisms responsible for
increased frailty with age is critical for improving heathspan in older adults. The goal of this proposal is to
establish a novel role for supraoptic hypothalamic neurons in causing age-dependent physiological disturbances
which disrupt neuroendocrine homeostasis. Guided by our recent finding that arginine-vasopressin (Avp)
transcription in supraoptic hypothalamic neurons is dramatically increased in aged mice, the proposed
experiments leverage state-of-the-art methods for monitoring and manipulating vasopressin neurons in mice with
the goal to elucidate their role in thermoregulation and fluid balance. This proposal will also explore the role of
brain inflammation in altering physiological homeostasis through dysregulation of vasopressin neuronal function.
Finally, the therapeutic potential of gene therapies focusing on vasopressin neurons will be investigated in the
context of behavioral and physiological frailty with age. The proposed studies will lay the groundwork for imputing
a causal role of supraoptic vasopressin neurons in the onset of age-dependent frailty.

Public health relevance
PROJECT NARRATIVE The proposed research is highly relevant to public health as it delves into the role of the supraoptic nucleus of the hypothalamus, a key component of the neuroendocrine pathway, in driving physiological decline and the development of chronic diseases of aging. Understanding the mechanisms behind this pathway's involvement in aging could pave the way for the development of targeted therapeutic interventions to promote healthy aging and combat geriatric diseases, ultimately improving the quality of life and longevity of millions.